Sphingolipids, Dietary Fatty Acids, and Intestinal Pathophysiology

Diets high in fat have been linked to obesity, and a high fat diet (HFD) has been implicated in altering intestinal function, including inflammation; however, the contribution of specific HFDs and their predominant fatty acids (FAs) on key pathophysiologic processes is largely unknown. Studies with trans-fats, lard, olive oil, fish oil, plant- based fats (corn oil, soybean, etc.) have demonstrated that specific sources of FAs exert extremely diverse effects in disease, most commonly in cardiac and metabolic disease. Therefore, the long-term goal of this proposal is to dissect the complexity of components and effects of specific dietary FAs on gut pathobiology and determine the mechanisms involved. Specifically, we aim to define the specific roles of two ceramide-generating enzymes, ceramide synthases (CerS) 5 and 6, in the regulation of myristate-induced activation of inositol requiring enzyme 1α (IRE1α) and define their critical roles in intestinal homeostasis and pathophysiology. IRE1α is a critical branch in the unfolded protein response (UPR) or ER stress and is an evolutionarily conserved signaling mechanism to overcome stress in the ER, resulting in a pause of new protein synthesis and induction of chaperone proteins to restore normal ER function. Functionally, ER stress and IRE1αv have been linked to alterations in intestinal homeostasis and inflammation. Specifically, ER stress genes are upregulated in intestinal epithelial cells (IECs) from a murine experimental colitis model (IL10-deficient)1 and in IECs or biopsies from inflammatory bowel disease (IBD) patients1,2. IRE1α, as well as other effectors of ER stress, can be initiated by several triggers including high fat diet (HFD) or treatment with saturated FAs, as well as exogenous and endogenous sphingolipids3-5. These important clues in the literature, together with our studies on bioactive sphingolipids in intestinal inflammation, led us to investigate the role of specific dietary FAs in sphingolipid metabolism and their role and mechanism(s) of action in intestinal ER stress. Our very novel observations demonstrate that the C14 saturated FA myristate (rich in milk based diets), but not palmitate (C16 saturated FA), increases ER stress, as well as inflammation in IECs in culture and in mouse intestinal tissues in vivo6. Mechanistically, ceramide synthases 5 and 6 (CerS 5 and 6) are required for the activation of IRE1α branch of the UPR, inducing splicing of XBP1 and expression of IL66. Importantly, these data now lead us to the hypothesis that CerS5/6 and the generation of C14 ceramide regulate IRE1α in the intestine and that this may mediate specific responses in intestinal pathobiology (specifically intestinal inflammation). To test this hypothesis, we propose the following specific aims: Specific Aim 1. Determine the role of CerS5/6 in the regulation of ER stress, specifically IRE1α, in intestinal epithelial cells and intestinal organoids. Specific Aim 2. Define the role of CerS5/6 in ER stress-mediated intestinal pathobiology in vivo.

Public health relevance
ER stress signals resolve cellular stress or lead to apoptosis. Functionally, ER stress has been linked disrupted intestinal homeostasis and inflammation. The studies in this proposal will establish sphingolipid enzymes and their lipid products as regulators of diet-induced ER stress and define their effects in intestinal inflammation.